Immune Regulation of COVID-19 Infection in Cancer and Autoimmunity

Abstract
COVID-19 infection is greatly heterogenous. Individuals with underlying immune dysregulation,
will have abnormal responses to COVID-19, thereby accounting for different short-term outcomes
and memory formation. Specifically, emerging evidence indicates poor outcomes in autoimmune
and cancer patients. We propose that autoimmune patients and severe COVID-19 infection will
share an exacerbated pathological response while cancer patients with disease-associated or
treatment-induced immune deficiency, will fail to mount a protective anti-viral response. Here, we
shall interrogate the effector B cell response to SARS-CoV-2 to identify determinants of protective
and pathogenic responses in HC and autoimmune subjects.

Public health relevance
Project Narrative Non-Applicable